ZDV VS DDI VS ZDV PLUS DDI PLUS NEVIRAPINE IN ASYMPTOMATIC HIV PATIENTS

A Double-Blinded, Randomized Trial Comparing Zidovudine (ZDV) vs ZDV + Didanosine (ddI) vs ZDV + ddI + Nevirapine in Asymptomatic Patients on ZDV monotherapy who develop a mutation at condom 215 of HIV reverse transcriptase in serum/plasma viral RNA (ACTG 244).